Postdoctoral training in tobacco control

ABSTRACT
We have one specific aim: Train postdoctoral fellows who will be qualified and well-positioned to
become leaders in the development and implementation of substance use research in tobacco control,
public health, policy, and clinical practice. Specifically, we propose a postdoctoral fellowship program that will
attract individuals with a strong commitment to transdisciplinary research from a variety of medical, biological,
social, behavioral, and policy sciences to help build the next generation of scientific leaders in tobacco control
and related substance use. Tobacco remains the leading preventable cause of death the U.S. and
disproportionately burdens people with substance use disorders.
The need for tobacco control expertise continues to grow with demand for research to inform FDA
regulation of tobacco products, the implementation of the WHO Framework Convention on Tobacco
Control, and state and local tobacco control efforts to address the rapidly evolving tobacco product
environment. Considering the high rates of tobacco co-use with other substances, our program is expanding
on points of synergy between tobacco, cannabis and opioid research. This includes training in: 1) Research on
tobacco and cannabis co-use and cannabis health effects to inform policy and develop evidence-based
interventions and 2) Research on industry behavior that has driven both the tobacco and opioid epidemics and
is likely to become increasingly important with cannabis legalization. We provide this training through
integrated transdisciplinary coursework in tobacco science, tobacco policy, addiction, and biostatistics,
combined with mentored research with two faculty from different disciplines. Fellows complete a course in
which they prepare, and submit grant proposals to funding agencies for their third year of fellowship funding.
Research mentors include 31 faculty members from all four schools at UCSF (Dentistry, Medicine, Nursing,
and Pharmacy) with active research programs in tobacco policy, marketing, addiction, health effects of
smoking and secondhand smoke exposure, emerging tobacco, cannabis and vaping products, cessation,
cannabis substitution for opioids, and analyses of tobacco and opioid industry documents. The diverse fellow
backgrounds and interests in the Center for Tobacco Control Research and Education provides a cooperative
environment that creates continuous opportunities to learn from and appreciate work in other disciplines. Each
fellow creates an Individual Development Plan that is reviewed by both mentors and the Fellowship
Committee. The Committee selects fellows from a competitive national pool: we average 29 applications per
year for 3 slots. Between 2016-2021, our fellows produced 135 papers in 68 different journals. Since 2001, we
have trained 92 fellows (62 funded by NIH training grants since 2006); 93% of our R25/T32 graduates have
research careers in academic, government and nongovernmental institutions, and 54% are academic faculty.

Public health relevance
PROJECT NARRATIVE Tobacco remains the leading preventable cause of death in the U.S. and is also the leading preventable cause of death among people with substance use disorders. This innovative training program has a primary focus on tobacco with emerging areas of focus on cannabis and tobacco co-use and industry research that extends from tobacco to pharmaceutical opioids. We will prepare the next generation of leaders in substance use and addiction science with a combination of coursework and mentored research in a collaborative environment that has a proven record of integrating multiple disciplines to translate science to improve public health policy and clinical practice.